Synchronous network activity in the maturing prefrontal cortex: mechanistic impact of birth timing and serotonin

PROJECT SUMMARY
The brain functionally matures during postnatal windows of heightened plasticity, known as the critical or
sensitive periods. While postnatal experience-dependent critical periods depend on inhibitory neurotransmission,
the early neonatal critical periods depend on the patterns of intrinsic activity, serotonin signaling and the timing
of birth. In sensory areas, intrinsic activity and birth-triggered serotonin signaling support the establishment of
sensory maps. However, their roles in the development of frontal areas are unclear. Preliminary studies for this
proposal found that the timing of birth drastically impacts intrinsic activity, with reduced synchrony in neonate
mice born a day early (preterm mice). Preterm mice have deficits in cognitive function and cortical inhibition,
suggesting that birth-triggered neonatal critical period supports the establishment of prefrontal circuits for
cognitive function. This proposal uses a combination of in vivo electrophysiology, optogenetics, chemogenetics,
confocal imaging, and behavioral assays to mechanistically determine the impact of premature birth and
serotonin signaling on prefrontal development, and to test whether postnatal manipulation of intrinsic activity and
serotonin can rescue the circuit and behavioral deficits in preterm mice. Through innovative approaches in a
novel animal model, this proposal will shed light on the early steps in circuit development whose impairment can
increase the risk of atypical neurodevelopment.

Public health relevance
PROJECT NARRATIVE The earliest critical period in brain development is regulated by the timing of birth and serotonin signaling, but its role in the establishment of frontal circuits that support cognitive function is unknown. This proposal uses a broad combination of tools for probing circuit function to determine how neonatal patterns of intrinsic cortical activity and serotonin signaling shape the development of prefrontal circuits in mice.